Access to Strained Rings and Heterocycles: Applications in the Synthesis of Bacterial Metabolites and Chemical Building Blocks

Project Summary/Abstract
The studies described in this proposal seek to develop strategies for the synthesis of strained rings and
heterocycles for two purposes: 1) the first total syntheses of novel azetidine-containing metabolites, and 2) rapid
access to bifunctional strained ring and heterocycle building blocks. Regarding the first purpose, total syntheses
of azetidomonamide A, azetidopyridone, and diazetidomonapyridone do not exist and are sorely needed so their
biological functions in quorum-sensing behavior can be evaluated. These metabolites affect biofilm formation
and production of redox-active metabolites in P. aeruginosa, which is partially implicated in adverse outcomes
for cystic fibrosis patients. Thus, total syntheses of these metabolites are highly needed and will have a broader
impact on human health through expanding understanding of biofilm formation by P. aeruginosa, and potentially
allowing for development of anti-virulence treatments for it in the long term. For the second purpose, strained
rings and heterocycles are increasingly prevalent in pharmacological motifs; strategies to access modular
components are needed to enable expedient diversification and access to new bioactive molecules.
For the syntheses of azetidomonamide A and diazetidomonapyridone (K99), we envision the
development of intramolecular cyclization reactions to establish key challenging frameworks in the molecules,
such as Z-exocyclic azetine moieties, 4/6 bicyclic pyridones, and 4/7 bicyclic carbamates. These efforts will not
only allow us to establish the total syntheses of these metabolites, but contribute more broadly to chemical
synthetic efforts in the development of new reactions to access these strained heterocyclic motifs.
In the R00 component, we propose the development of organometallic methods to achieve the syntheses
of bifunctional strained ring and heterocycle chemical building blocks. In the first phase, we anticipate diverting
organometallic intermediates to Favorskii-type reactivity to generate N-heterocycles that contain multiple
handles for further functionalization; in the second, we propose tuning organometallic intermediates to Ramberg-
Bäcklund reactivity to access substituted strained-ring derivatives. In doing so, we will broaden knowledge of
current chemical reactivity as well as provide strategies to make molecular scaffolds relevant to multiple
industries, including those pertaining to pharmaceuticals.
Overall, the proposed research is significant because it provides creative strategies to 1) establish the
first total syntheses of azetidomonamide A and diazetidomonapyridone, which will enable their biological study,
and 2) develop new reactivity paradigms for accessing modular molecular scaffolds with pharmacological
relevance. Performing the K99 research in Prof. Reisman’s group at Caltech aligns well with their current success
in the efficient total synthesis of complex natural products; this experience in the synthesis of strained
heterocycles will augment my prior training in organometallic chemistry to prepare me for a future R1 academic
career in which I develop methods to access these types of motifs in broader contexts.

Public health relevance
Project Narrative/Abstract Heterocycles and strained rings are valuable motifs in pharmaceuticals and natural products, thus highlighting the need for unique ways to access them. The K99 phase will establish the first total syntheses of azetidine- containing metabolites that affect biofilm and pigment production in the pathogenic bacterium P. aeruginosa; the R00 phase will center on development of distinctive methods to access multifunctional chemical building blocks. This project is relevant to the NIH’s mission because 1) in the short-term, it will expand fundamental knowledge in the synthesis of bioactive natural products and pharmaceutically relevant motifs, and 2) in the long-term, findings from biological studies of molecules in the K99 phase could lead to new anti-virulence treatments for those infected with P. aeruginosa, and methods in the R00 phase could aid in rapid access to pharmaceuticals.